Identifying shared and distinct cell type vulnerability across neurological diseases.

PROJECT SUMMARY
A central question in neurodegeneration research is to identify type-specific changes associated with the onset
and progression of neurological disease. Currently, studying alterations in cell type composition, signatures, and
function in response to pathology are areas of active investigation in Alzheimer's Disease (AD), Parkinson's
Disease (PD), Huntington's Disease (HD), and Amyotrophic Lateral Sclerosis-Frontotemporal Dementia (ALS-
FTD) research. For polygenic diseases such as AD, PD, and ALS-FTD, genome-wide association, bulk tissue
transcriptomics, and bulk proteomics studies have highlighted candidate loci, genes, and proteins with significant
associations to pathological and clinical manifestations of diseases. However, these efforts are focused
separately on each disease; thus, the major gap is a lack of studies that systematically examine tissue from the
same brain regions from individuals with different neurodegenerative diseases. Here, we aim to contextualize
disease-specific bulk tissue findings using cutting-edge techniques at single-cell resolution to characterize
commonalities and differences in cell type-specific changes across different neurodegenerative diseases. Such
cross-disease investigation is likely to shed light on each disease individually, by linking specific cell type
changes to pathologies that are hallmarks for a particular neurodegenerative disease. In parallel with data
generation and analysis, we also aim to create a standardized, cross-disease interactive portal for investigators
to explore not only cell type-specific signatures that are associated with individual neurodegenerative diseases
like AD, but also signatures that are shared between AD and other diseases. This approach will not only further
our understanding of AD-specific cell type vulnerability, but also distinguish between specific and general
signatures of neurodegeneration in multiple other diseases. Thus, our overall goals are not only to create a
foundational data set to refine our understanding of cell type vulnerability and alteration within AD and across
other neurodegenerative diseases, but also to establish a robust framework to allow external researchers to
derive new disease-specific insights into cell type composition changes in neurodegeneration.

Public health relevance
PROJECT NARRATIVE Neurodegenerative diseases have differential effects on cell types in the brain, whereby some cells are preferentially vulnerable whereas others seem more robust to the effects of disease pathology. However, there is a gap in our knowledge of which cell type-specific changes are unique to a given disease, and which changes are found in multiple diseases such as Alzheimer's Disease, Parkinson's Disease, Huntington's Disease, and Frontotemporal Dementia. This proposal aims to examine post-mortem brain tissue at single-cell resolution to identify shared and disease-specific signatures across this range of neurodegenerative disorders.